DEPRENYL AND TOCOPHEROL ANTIOXIDATIVE THERAPY OF PARKINSONISM

The purpose of this study is to determine whether the neuronal degeneration and subsequent dopamine depletion in Parkinson's Disease is due to an environmental toxin or an endogenous prototoxin.